Malaria parasite determinants of host cell tropism

PROJECT SUMMARY
Malaria continues to be a major scourge of humanity, and is caused by infection of red blood cells (RBCs) by
the protozoan Plasmodium spp. parasites. Plasmodium falciparum can achieve high parasite biomasses in the
circulation causing severe morbidity and mortality. Blood-stage parasites have a strict cellular tropism for RBCs,
interacting with numerous molecular determinants in the RBCs for productive infection and transmission.
Parasite polymorphisms that allow parasites to propagate and persist in different types of RBCs present a major
challenge to malaria control and elimination. This includes the ability of the invasive merozoite forms to use
different receptors on RBCs, known as invasion pathways. We will leverage the power of forward genetics to
identify the molecular determinants mediating two key features of the cellular tropism of P. falciparum: RBC age
and RBC species preference. We have found that different P. falciparum strains vary significantly in these
preferences, and hypothesize that the parasite polymorphisms underlying this variation are critical to the
emergence and persistence of P. falciparum in human populations, and are key determinants of pathogenesis
and transmission. We will employ a forward genetics approach to identify polymorphisms and genes associated
with RBC age and species preference, specifically Bulk Segregant Analysis (BSA) of progeny from genetic
crosses of P. falciparum parental lines with varying invasion preferences. Reverse genetics approaches will be
used for the functional analysis of naturally occurring polymorphisms in candidate genes, both singly and in
combination. Together these studies will provide a comprehensive understanding of the molecular basis of
cellular tropism in P. falciparum parasites, focused on RBC age and species preference. In the long-term we
hope that our studies will elucidate the critical interactions required for the persistence, pathogenicity and
transmission of P. falciparum in parasite populations, to inform public health interventions and inform vaccine
development.

Public health relevance
PROJECT NARRATIVE Malaria is caused by infection of red blood cells (RBCs) with Plasmodium parasites and can result in severe or even fatal disease. Parasite polymorphisms that allow parasites to proliferate or persist in specific cell types present a major challenge to malaria disease control and elimination, respectively. Here, we propose to elucidate the molecular basis of two particular parasitic features that are of great public health importance, both for designing appropriate interventions and for anticipating the emergence of new strains into the population: the preference of P. falciparum for the youngest of human RBCs known as reticulocytes, and the adaptation of P. falciparum to human RBCs from gorilla cells.